Short-Term Training Program In Biomedical Sciences

Project Summary/Abstract
This application is a competitive renewal of the NHLBI T35 training grant (Short-Term Training in Biomedical
Sciences) awarded to Indiana University School of Medicine (IUSM) in 2011 and 2016. This T35 greatly
contributed to the consolidation and expansion of the IUSM Student Program for Research and Scholarship
(IMPRS). The purpose of the IMPRS program is to provide a structured research environment that engages
medical students’ interest in biomedical research, creating opportunities for basic and translational research
experience and education in research ethics. The main objective of the T35 is to serve as a portal to train and
recruit physician-scientists. To meet the ongoing and increasing demand of IUSM medical students for
opportunities to engage in biomedical research and to expand program diversity, this application seeks support
to continue to enroll 32 highly motivated and diverse students/year within the IMPRS program to conduct
research in cardiovascular, respiratory and hematopoietic disease in basic and clinical departments and
centers at IUSM. This level of support is justified by sustained (and actually, growing) student participation,
increased trainee diversity, and excellent student outcomes. In parallel, we have significantly strengthened our
pool of mentors by recruiting an unprecedented pool of diverse and robustly NHLBI-funded researchers to
IUSM over the last five years, thus providing an innovative and diverse training environment in
cardiopulmonary, hematological and cancer research. Lastly, the program is now at an exciting inflection point,
where several of the first generation of T35 trainees are pursuing research in research-heavy fellowships or
are working in academic faculty positions, and bringing these alumni back to the program will provide a highly
valuable experience for the current trainees. This T35 training program serves as a central portal to recruit and
train students through active engagement in a diverse array of laboratory, translational and clinical research
and builds on the growing student participation and increasing mentor pool. With renewed T35 support, IMPRS
can maintain and improve medical student engagement in IUSM’s cutting-edge research programs. In
particular, the program is designed to a) increase student awareness of the value of engaging in biomedical
research by challenging students to take on independent projects during the internship; and b) support students
interested in careers in academic medicine. This occurs through 1) providing access to opportunities for
research presentation and publication, and 2) fostering engagement with degree programs such as the IUSM
MD/PhD program, the Clinical Investigation and Translational Education program, the Indiana Clinical and
Translational Sciences Institute medical student gap year for research program, or external research
fellowships. The long-term goal of the program is to increase the numbers and diversity of physician scientists
nationally by exposing students in their early years of medical education to hypothesis-driven research focused
on the molecular and cellular basis of disease and the potential for clinical translation.

Public health relevance
PROJECT NARRATIVE The Indiana University Medical Student Program for Research and Scholarship at the Indiana University School of Medicine has established a pipeline for medical students to enter research intensive programs such as MD/PhD, MD/MS, or gap year programs, and more broadly to encourage them to embrace the career of physician-scientists. The purpose of this T35 renewal program is to continue to sustain this program and to support intensive research training (3 months) for 32 medical students in basic and translational research in the areas of cardiovascular disease, respiratory disease and hematopoiesis with highly trained investigators/mentors and in a stimulating environment.